Nurse LEADS: Training in Nurse-LEd models of care ADdressing the Social Determinants of Health

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Community health, including the conditions in which people are born, grow, live, and age, contribute to up to 80% of population health outcomes. Nurses, as the largest and most trusted segment of the healthcare workforce, are uniquely positioned to lead national efforts addressing population health. However, nurse scientists responsible for generating evidence for care models have not typically received specialized research training in addressing community health. Additionally, a lack of access to education in nursing science in certain geographical regions in the U.S. limits the profession's ability to engage all populations in research. Our proposed training program, Nurse LEADS (Training in Nurse-LEd models of care ADdressing Systems of Care and Community Health), is designed to provide innovative training to nurse scientists at the intersection of population and community health and nurse-led models of care. Trainees will develop skills in digital health, advanced analytics, engagement science, and multisector partnerships as essential methodological approaches and tools for promoting population health. Specifically, Nurse LEADS aims to: 1) recruit and retain pre- and postdoctoral trainees (N=10) in nursing science for advanced research training in community and population health and nurse-led models of care; 2) support trainees in contributing to emerging theoretical frameworks and methodological approaches for developing and scaling nurse-led models of care addressing community and population health; 3) develop trainee methodological expertise in leveraging digital health and advanced analytics for conducting cutting-edge research evaluating nurse-led models of care addressing population and community health; 4) and apply engagement science and multisector partnerships in the development of nurse-led models of care addressing population and community health. Trainees will be supported by mentoring teams that include mentors addressing digital health, advanced analytics, and community and population health from nursing and other interdisciplinary backgrounds. Trainees will participate in career development activities, monthly Nurse LEADS seminars, three courses involving experiential learning practicums, tailored learning experiences drawing from seminars, workshops, and courses from participating departments at Duke, and training in the responsible conduct of research. Additionally, postdoctoral trainees will be required to complete pilot research contributing to a nurse-led model of care addressing population and community health and mentor predoctoral trainees. This novel training will enhance the capacity of nurse scientists across to the U.S. to create novel, evidence-based models of care to improve population health.

Public health relevance
Addressing community conditions is a key strategy to improve population health. This training program will increase access to specialized training in nursing science and provide nurses with skills in developing, testing, and scaling nurse-led models of care that address community and population health.